Multimodal Characterization of Cerebral Reorganization in Children with Unilateral Cerebral Palsy

PROJECT SUMMARY
Cerebral palsy is the most common pediatric movement disorder and is caused by
damage to brain areas during development. Children with unilateral cerebral palsy (UCP), the most
common form of cerebral palsy, have unilateral impairments that cause muscle weakness, poor
coordination, and difficulty grasping objects. These upper-extremity (UE) impairments reduce children's ability
to participate in age-appropriate activities. There is an urgent need for effective hand therapies based on
mechanisms of motor recovery. Growing evidence indicates that skill-based training affords the opportunity to
capitalize on residual brain plasticity in children with UCP and improve hand function. Yet, the diversity of brain
injuries, and subsequent brain reorganization in children with UCP, leads to heterogeneous outcomes even for
the most established therapies. Our long-term goal is to optimize the effectiveness of therapies by adapting
them to the individual characteristics of children with UCP. A critical precursor to this goal is characterizing how
motor pathways adapt following perinatal brain injury. However, how best to examine brain networks
underlying control of the affected UE remains unknown. The objective of this project to use a multimodal
approach to identify atypical functional and anatomical patterns of connectivity in children with UCP and relate
these patterns to impairment in unimanual and bimanual function. Characterizing mechanisms of motor
pathway reorganization will serve as a critical precursor to the development of individualized rehabilitation
approaches. We propose to use measurements of functional cortical activity (i.e. functional near-infrared
spectroscopy) and transcranial magnetic stimulation to determine the unique brain areas responsible for
control of the affected upper-extremity in children with UCP. We will examine these patterns in relation to
standardized assessments of dexterity and performance of bimanual skills. We will leverage the information
gained from this study to generate new hypotheses about potential neural targets for functional recovery. Thus,
our work will inform the design of a future large-scale trial testing neurorehabilitation strategies based on
individual motor pathway reorganization.

Public health relevance
PROJECT NARRATIVE Unilateral cerebral palsy is the most common pediatric neurologic disorder of movement and prevents functional independence during early childhood. The goal of the current proposal is to characterize how brain pathways controlling movement adapt to early injury in children with unilateral cerebral palsy, and to examine these patterns in relation to movement deficits. The knowledge gained from this study will provide the foundation for testing future precision-based approaches to neurorehabilitation and will have broad clinical implications for pediatric movement disorders.